NCI Research Specialist (Clinician Scientist) Award

Project Abstract
I am a Pediatric Hematologist-Oncologist at the Dan L. Duncan Comprehensive Cancer Center’s
Pediatric Cancer Program (DLDCCC PCP), with dual board certifications in Pediatric Hematology-
Oncology and Clinical Pharmacology. I have clinical and research expertise in developmental
therapeutics, neuroblastoma, and other pediatric solid tumors. I am committed to a career as a
clinician-scientist, serving as a national leader in the development of national clinical trials and
the implementation of NCI clinical trials at my institution and contributing to NCI clinical trial
networks through participation in both scientific review and monitoring committees. My clinical
and research interests are focused on ushering novel therapies into early-phase clinical trials for
patients with neuroblastoma and other pediatric solid tumors and mitigating toxicities associated
with therapy.
Within the PCP, I am the Clinical Director of the Neuroblastoma Program, Director of the Solid
Tumor Program, and the Assistant Director of the Developmental Therapeutics (DVL) Program.
In these roles, I lead and implement therapeutic clinical trials for pediatric patients with solid
tumors and early-phase clinical trials for pediatric cancer patients with relapsed or refractory
disease. In addition, I contribute to the national leadership of the NCI-funded Children’s Oncology
Group (COG) and Pediatric Early Phase Clinical Trial Network (PEP-CTN) as a member of three
steering committees (Cancer Control, Neuroblastoma Biology, and Neuroblastoma); a committee
member for two clinical trials treating patients with high-risk neuroblastoma; Study Chair for an
ongoing phase 1 trial; a member of the PEP-CTN Performance Monitoring Committee; and site
PI for the PEP-CTN at my institution. Additionally, I mentor young investigators both at my
institution and through the national COG mentoring program. I attend and present annually at the
COGs Fall and Spring meetings. Greater than 50% of my effort is dedicated to PI responsibilities,
patient consent and enrollment activities, and administrative responsibilities directly related to my
COG and PEP-CTN activities.

Public health relevance
Project Narrative My experience, productivity, qualifications, and accomplishments are critical for the successful implementation of clinical trials through the Dan L. Duncan Comprehensive Cancer Center’s Pediatric Cancer Program (DLDCCC PCP). My leadership accomplishments within the NCI- sponsored COG ensure the continued development and implementation of innovative clinical trials for pediatric oncology patients. The funding opportunity outlined in this application is essential for providing the dedicated time needed to continue fulfilling the mission of the DLDCCC.